Comparative Functional Genomics (CFG) Core

COMPARATIVE FUNCTIONAL GENOMICS CORE PROJECT SUMMARY
Biomedical research is increasingly dependent on the collection of genome-scale data that require
robust procedures to facilitate rigorous and reproducible experimental design and analysis of resulting data
sets. Collaborative genome-scale research efforts additionally require detailed and careful planning for
sharing, integration, and joint analysis of experimental results. During COBRE Phase I, the Comparative
Functional Genomics (CFG) Core was established and formed an essential cornerstone of the research
programs of scientists working in the Kathryn W. Davis Center for Regenerative Biology and Medicine. The
CFG Core played a fundamental role in the success of Phase I, providing computational consultation and
services across all supported research projects. The Core also created the Comparative Models of
Regeneration Database, RegenDbase, a shared data management and analysis resource for studies of tissue
regeneration. In COBRE Phase II, the CFG Core will support COBRE Project Leaders by providing shared
expertise and services in data management and analysis, and by continuing further development and
expansion of RegenDbase. RegenDbase will be updated and enhanced by the expansion to new experimental
data types, e.g., proteomics and epigenetics, as well as the integration of critical external datasets to facilitate
analysis and interpretation of the experimental data. The Core will ensure rigorous and reproducible analysis
through use of state-of-the-art best practices in computational approaches, including automation, version-
control, and detailed logging of all analysis workflows. Core personnel will also conduct an annual training
session in data management and computational analysis for all research staff in the Davis Center. In
summary, the CFG Core will continue to provide expertise and services in data management, genomic
analysis, and software engineering that COBRE Project Leaders need to accomplish their research goals.